Combining Targeted RIT and Synergistic Novel Agent-Renewal

PROJECT SUMMARY/ABSTRACT (From Parent Grant Application)
Potentially curative treatments for acute myeloid leukemia (AML) are limited to intensive systemic chemotherapy
with or without allogeneic bone marrow transplantation (BMT). However, not every patient is healthy enough to
tolerate intensive treatments, and not every patient may have a suitably HLA-matched stem cell donor, especially
patients from ethnic minority groups. Targeted agents have recently been approved to treat AML, but these
usually require intensive systemic chemotherapy to optimize efficacy. Furthermore, AML is genetically
heterogeneous with distinct genetic mutations and chromosomal alterations that makes targeted-agent
monotherapy unlikely to be curative. AML, like most hematologic malignancies, is very sensitive to radiation
therapy but even involved field radiation may be too toxic and ineffective for disseminated systemic disease.
However, radioimmunotherapy (RIT) mitigates the off-target toxicity by using monoclonal antibodies conjugated
to radioactive isotopes to deliver radiation payloads directly to sites of disease by virtue of the antibody specificity.
We have shown that RIT using 90Y- and 131I-radiolabeled anti-CD45 antibody targets radiation to sites of leukemia
while minimizing radiation to uninvolved organs. We have improved upon our approach without increasing
toxicity by targeting higher energy alpha-emitting radionuclides (astatine-211; 211At) to sites of disease and by
developing a pre-targeted RIT (PRIT) approach using bispecific antibodies targeting CD45 and 90Y-DOTA.
Using preclinical murine models, we now propose to identify synergistic combinations of 211At- and 90Y-anti-CD45
RIT with novel targeted therapies that interfere with DNA repair or promote apoptosis. We will do this by first
assessing for synergy between alpha- or beta-emitting radionuclides (211At- and 90Y-) employed in anti-CD45
directly labeled RIT with recently approved targeted agents (PARP and BCL2 inhibitors) in both disseminated
syngeneic and xenograft leukemia murine models. Second, we will improve therapeutic efficacy of anti-CD45
PRIT via bispecific antibody constructs targeting CD45 and 90Y-DOTA by assessing for synergy with targeted
therapies (PARP and BCL2 inhibitors) in leukemia murine models. We will characterize the extent of DNA
damage achieved with these two approaches as a means to elucidate the mechanism of efficacy. Finally, we will
compare these two approaches as part of conditioning prior to allogeneic BMT using haploidentical, or partially
matched donors, as all patients should have haploidentical donors.
These preclinical studies should readily translate into clinical trials given our infrastructure for NIH funded and
pharmaceutical-sponsored clinical trials, using anti-CD45 RIT prior to bone marrow transplantation for
aggressive hematologic malignancies. These studies will add effective, well-tolerated treatment options for
patients with AML by identifying synergistic combinations of targeted agents with anti-CD45 RIT approaches and
by identifying the optimal RIT approach prior to haploidentical BMT.

Public health relevance
PROJECT NARRATIVE (From Parent Grant Application) Although favorable responses have been attributed to recently approved targeted agents for the treatment of hematologic malignancies, such as acute myeloid leukemia (AML), the diversity of genetic mutations within blood cancers limits the curative potential of targeted monotherapies. However, hematologic malignancies are especially vulnerable to radiation, and thus genetically diverse sub-clones may all be eliminated by targeting radiation directly to the sites of disease through the powerful technology of radioimmunotherapy. This grant proposes to improve outcomes for AML by: 1) identifying synergistic combinations of radioimmunotherapy approaches with highly effective, but not yet curative, targeted agents; 2) correlating efficacy with the extent of DNA damage achieved by synergistic combinations; and 3) by comparing these radioimmunotherapy combinations as preparative chemotherapy prior to allogeneic bone marrow transplantation.